BCOR/PRC1.1 Inactivation In Splicing Factor Mutant MDS Progression

PROJECT SUMMARY:
Myeloid malignancy is characterized by the acquisition of mutations in a stereotyped order with distinct patterns
of cooperating mutations. Mutations in genes that alter polycomb repressive complex (PRC) function, such as
BCOR, are strongly associated with acute myeloid leukemia (AML) arising from myelodysplastic syndrome
(MDS). BCOR inactivating mutations disrupt non-canonical PRC1.1 complex assembly and cause the de-
repression of target genes involved in leukemogenesis. We found that among patients with U2AF1 mutations,
BCOR mutations were enriched exclusively in those with the S34F mutation. This proposal seeks to leverage
this unique U2AF1 codon-specific co-mutation to define the mechanisms by which BCOR/PRC1.1 inactivation
promotes splicing factor mutant MDS progression. I have assembled a cohort of 4,193 patients with myeloid
malignancies and generated isogenic K562 cell lines and genetically engineered mice to model U2AF1S34F and
BCOR co-mutation. My preliminary data indicate that U2AF1 mutation context affects the transcriptional output
of BCOR/PRC1.1 inactivation and the combination of U2af1S34F and Bcor deletion in mice causes the most
severe hematologic abnormalities. My central hypothesis is that U2AF1S34F enforces the conditional selection of
subclonal BCOR/PRC1.1 inactivation by modulating PRC1.1 target gene expression to promote clonal
expansion and worsening ineffective hematopoiesis, hallmarks of MDS progression. Aim 1 will define the clinical
and genetic pathways of BCOR/PRC1.1-mediated MDS progression. Aim 2 will determine the differential effect
of U2AF1S34F versus U2AF1Q157P mutations on BCOR/PRC1.1 localization, function, and target gene expression.
Aim 3 will determine the impact of Bcor/PRC1.1 inactivation on U2af1S34F mutant hematopoiesis in vivo. The
long-term goals of the proposed research are to gain fundamental insights into how PRC1.1 and splicing factor
dysfunction interact to promote MDS progression and inform therapeutic strategies for patients.
The applicant, Dr. Rahul Vedula, is an oncologist at Dana-Farber Cancer Institute (DFCI). He spends 80% of his
time engaged in translational research and 20% of his time in clinical practice caring for patients with hematologic
malignancies. Dr. Vedula has outlined a five-year career development plan that will enable him to meet his goal
of becoming an independent translational investigator focused on myeloid disease progression. Dr. Vedula will
perform the proposed research under the mentorship of Dr. Coleman Lindsley, an expert in myeloid biology and
clonal hematopoiesis. Dr. Vedula has assembled a scientific advisory committee of internationally recognized
experts to provide scientific and career mentorship. He will obtain additional training in the use of mouse models
for hematologic malignancy research, computational biology, and biostatistics through collaborations and
coursework. Dr. Vedula will conduct the proposed research at DFCI, a rich research environment with a long
track-record of training successful physician-scientists.

Public health relevance
PROJECT NARRATIVE Myelodysplastic syndromes (MDS) are defined by the hierarchical acquisition of genetic mutations in the bone marrow resulting in ineffective hematopoiesis and propensity to transform to acute myeloid leukemia (AML). This project seeks to determine the mechanisms by which inactivating mutations in BCOR, a recurrently mutated core component of the non-canonical polycomb repressive complex 1.1 (PRC1.1), interact with mutations in the RNA splicing factor U2AF1 to mediate MDS progression. The proposed research will advance our understanding of PRC1.1 dysfunction in hematopoiesis and myeloid malignancy development with the potential to improve surveillance and treatment strategies for MDS patients.